CALLOSAL THICKNESS IN ADHD

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Corpus callosum morphology will be assessed in healthy controls and patients with Attention-Deficit/Hyperactivity Disorder (ADHD). The corpus callosum region will be delineated manually following a defined tracing protocol. Computational surfaced-based techniques to encode callosal thickness at high resolution will then be applied to compare groups.